Clonal Hematopoiesis of Indeterminate Potential in Chronic Kidney Disease Patients

ABSTRACT
The 2017 publication of a landmark New England Journal of Medicine study linking clonal hematopoiesis of
indeterminate potential (CHIP) to atherosclerotic cardiovascular disease (ASCVD) ushered in a new paradigm
in vascular aging research. This work highlighted age-related somatic DNA mutation as an important
contributor to cardiovascular health, with CHIP thought to promote ASCVD primarily through inflammatory
sequelae. Despite the pro-inflammatory setting of chronic kidney disease (CKD), CHIP has not been assessed
for its contribution to end stage kidney disease and premature ASCVD among these patients. Hence, our
long-term objective is to characterize the role of CHIP and its related mechanisms in incident CKD
progression and ASCVD in a CKD setting. To achieve this overall objective, we will leverage the rich
resources of the Chronic Renal Insufficiency Cohort (CRIC) study, utilizing available whole exome sequencing
(WES) data for baseline CHIP measurement, longitudinally ascertained biospecimens, clinical information, and
molecular biomarkers, along with CKD progression and ASCVD events collected over 16 years of follow-up
study. We propose a discovery stage cohort of 2,126 CRIC participants who were 65 years of age or older at
baseline. Older adults are selected to maximize study efficiency, since CHIP is rare in younger adults. CHIP
status will be determined using baseline WES data and our state-of-the-art analytic pipeline for CHIP somatic
variant calling. We also propose repeated CHIP measurements at 3- and 6-years follow-up in the entire older
adult sub-cohort, along with RNA sequencing (RNA-seq) in 400 CRIC participants, half with CHIP. We will test
CHIP associations with incident CKD progression (Aim 1) and ASCVD (Aim 2) among the 2,126 CRIC CKD
patients. We will then evaluate upstream (Aim 3a) and downstream (Aim 3b) CHIP mechanisms in the unique
CKD setting using longitudinal information on CHIP and known risk factors for CKD progression and ASCVD,
including: clinical variables (blood pressure, glycemic traits, and lipids), biomarkers of kidney injury, cardiac
stress and injury, inflammation, and fibrosis, use of renin angiotensin aldosterone system inhibitors, and aging
related genetic factors (CDKN2A variants). To discover novel molecular mechanisms, our RNA-seq study will
test associations between CHIP and gene expression (Aim 4a). Differentially expressed genes will be
evaluated for association with CHIP mechanisms identified in Aims 3a and 3b (Aim 4b). To replicate findings,
we will leverage existing CHIP, clinical, biomarker, gene expression and outcome data in up to 4,126 Trans-
omics for Precision Medicine program and 8,520 UK Biobank participants. CHIP effects will be precisely
estimated in powerful meta-analyses of discovery and replication studies. Findings of the proposed research
could have broad implications, ranging from the improvement of risk stratification efforts to the development of
personalized strategies and novel molecular-based therapies for ESKD and ASCVD prevention in CKD.

Public health relevance
PROJECT NARRATIVE The proposed work aims to elucidate the role of clonal hematopoiesis of indeterminate potential (CHIP) in the progression of kidney disease and development of cardiovascular disease (CVD) in chronic kidney disease (CKD) patients. Knowledge gained from this study may contribute novel insights into the biological pathways underlying common CKD sequelae and help to identify CKD patients at high risk for kidney failure and CVD.